Speech Development and Brain Structure/Function in Infants with Isolated Oral Clefts: Relationship Anesthesia Exposure and Oxygenation

Project Summary/Abstract
The elevated risk of language and reading disorders (as high as 60%) among children with isolated cleft of the
lip and/or palate (iCL/P) is a significant clinical concern, substantiated by research since the 1980’s. These
disabilities, while not in the range of intellectual dysfunction, do result in academic achievement problems and
lower rates of college attendance. Neuroimaging work in children, adolescents, and young adults with iCL/P
has identified an association between these deficits and patterns of aberrant neural development and disrupted
activation during reading tasks. The critical next step in this line of work is to determine the etiology of these
language deficits and the associated neural patterns. Current hypotheses postulate that deficits may be due to
events very early in life, including 1) repeated exposure to anesthesia, 2) airway obstruction/reduced
oxygenation, and 3) genetic/biological factors disrupting neural migration and brain development. To fully
evaluate these theories, imaging work needs to be done on infants before and after their first surgery, with
information on oxygenation, pre-speech functioning, and neural development obtained in tandem. The lack of
such research is a crucial gap in the field, precluding essential information needed to inform clinical decisions
that may improve these outcomes (e.g., treatment protocols and appropriate interventions).
In the proposed study, infants with iCL/P and unaffected controls will undergo assessment at 2, 6-8, and 14-16
months of age; providing pre- and post-surgery measures for infants with iCL/P. At each time point, innovative
techniques of brain imaging (through MRI and fNIRS) and multi-modal assessment of speech/language (vocal
recordings and clinical ratings) will be combined with continuous overnight pulse oximetry and systematic and
structured medical chart review (for information on anesthesia exposure, clinically mandated sleep studies,
medical interventions, and audiology assessments). Through an R56 (NIDCR), the PI and research team have
demonstrated feasibility of this protocol with baseline data on 16 participants to date. Initial data reflects
patterns of immature pre-speech development, disrupted cortical growth and activation, and more desaturation
events for those with iCL/P prior to exposure to anesthesia.
The current project aims to: 1) Use baseline data to assess the effects of cleft presence and overnight
desaturation events on brain structure/function and pre-speech/language measures before exposure to
anesthesia; 2) Use data from all timepoints to assess the longitudinal effects of desaturation events and
exposure to anesthesia on neural and language outcomes for patients with and without iCL/P; and 3) Evaluate
the relationship between measures of neural structure/function and language outcomes. The longitudinal
approach and novel measures of pre-speech and neural functioning will significantly contribute to the
understanding of development in infants with iCL/P and the impact of exposure to anesthesia and reduced
oxygenation.

Public health relevance
Project Narrative The proposed research is relevant to public health by providing new data on rates and timing of hypoxia, impact of early exposure to anesthesia, and the earliest markers of brain growth/function among infants with and without oral cleft. This knowledge will be essential in guiding treatment decisions related to sleep studies, use of pre-surgical orthopedics, and timing of surgery that will ultimately improve outcomes for infants with oral cleft. The goals of this project advance the NIH mission to use obtained knowledge about living systems to enhance health and reduce disability.